Training in Visual Neuroscience

Project Summary/Abstract
This is a competing renewal application for funds to support pre- and postdoctoral
training in visual neuroscience at New York University in the Center for Neural Science
(CNS) and the Cognition and Perception Program in the Department of Psychology
(CP). We seek to renew training support for 6 predoctoral and 1 postdoctoral fellows.
This level of support is justified by the need for the training program to provide for the
training of a diverse yet coherent group of trainees. With the help of previous NEI
support, the Visual Neuroscience Training Program has become a leading center for
research training and has launched and shaped the careers of many who have made
important contributions to the field. The 20 faculty of the training program seek to
understand the visual system from a variety of disciplinary perspectives, but all share a
consistent focus on understanding visual function. The quality, experience, breadth, and
productivity of the training faculty has in the past and will in the future provide a fertile
intellectual environment in which young scientists can thrive. Three newly recruited
faculty have invigorated the program and made it even better, and have broadened its
reach into the general area of visual disorders. There is ample instruction through
courses and especially through mentoring in the research labs of CNS and CP that helps
bring trainees to the frontiers of vision research. Many active researchers supported by
NEI and other agencies provide direction, leadership, and support for students once they
emerge as more independent senior scholars. Extensive shared facilities, including MRI
scanners, an MEG and a TMS facility operated solely for research the two participating
departments, facilitate collaborations among faculty and trainees. The students who join
the CNS and CP doctoral programs are of outstanding quality and a very high proportion
have historically gone on to successful and in some cases stellar careers in visual
neuroscience.

Public health relevance
Project Narrative This project will train researchers in vision research, to provide the next generation of advances that will fuel national and international research progress in the visual sciences. The trainees will enhance our understanding of visual function and enable remediation of disabling diseases of the eye and central visual system.